Additive Manufacturing Wearable Magnetic Sensors: Revolutionizing Cardiac Health Monitoring with Machine Learning for Arrhythmia Classification

PROJECT SUMMARY
Magnetocardiography (MCG) measures the weak magnetic fields (1 - 100 picotesla, 0.1 - 100
Hz) generated by the heart’s electrical activities using superconducting quantum interference
devices (SQUIDs). It complements electrocardiography (ECG) by providing greater detail, as
MCGs are more sensitive to currents tangential to the chest surface and can detect vortex
currents. Due to its high independence from inhomogeneities in electrical resistivity inside the
torso and on the skin, MCG offers a practical alternative for monitoring various cardiac conditions.
However, SQUIDs require cryogenic cooling, specialized magnetic shielding rooms, and regular
maintenance, making them expensive and logistically challenging to operate. Additionally, their
bulkiness and complexity limit portability and require specialized training, further restricting
widespread use.
This SuRE project aims to advance MCG technology by combining additive-manufactured
organic granular magnetoresistive (OgMR) sensors with machine learning for superior cardiac
diagnostics. Unlike traditional magnetoresistive (MR) sensors such as giant magnetoresistive
(GMR), magnetic tunnel junction (MTJ), and anisotropic magnetoresistive (AMR) sensors, OgMR
sensors incorporate magnetic granules (typically nanoparticles) into organic semiconductors,
eliminating the need for thin film deposition and micro/nano-fabrication facilities, thus significantly
reducing fabrication costs. Additionally, OgMR sensors can be directly printed on flexible
substrates with consistent quality in high volumes. Our preliminary results indicate that OgMR
sensors offer 50 times higher MR compared to GMR sensors and comparable performance to
MTJs, making them a promising candidate for inexpensive, flexible, high-sensitivity magnetic
sensors for cardiac signal recording.
Given the advantages of OgMR sensors and the diverse expertise of the PI, Co-I, and
consultant, we aim to achieve the following specific goals: (1) additive manufacturing and
characterizing flexible OgMR sensors; (2) flexible OgMR sensor packaging and external circuit
design; (3) flexible OgMR sensors for cardiac rhythm recording and machine learning for cardiac
arrhythmias classification. We will develop a palm-sized circuit board with a 5 mm × 8 mm flexible
OgMR sensor for ex-vivo and in-vivo mouse cardiac rhythm recording. By the end of this project,
we expect to develop a portable OgMR sensing platform for MCG recording and a machine-
learning algorithm for the high-accuracy classification of normal and arrhythmic heart rhythms. In
the long run, our work aims to revolutionize the MCG technique and reduce healthcare costs.

Public health relevance
PROJECT NARRATIVE Magnetocardiography (MCG), a technique that records the magnetic fields generated by the heart's electrical activity using a superconducting quantum interference device (SQUID), is more sensitive to currents tangential to the chest surface and can complement electrocardiography (ECG), thereby improving clinical cardiac diagnostics in patients. Our SuRE project aims to use additive manufacturing to print inexpensive, high-sensitivity, wearable organic granular magnetoresistive (OgMR) sensors with micrometer-scale spatial resolution for MCG recording, combined with a machine learning algorithm for high-accuracy classification of normal and arrhythmic heart rhythms, providing superior cardiac diagnostics. OgMR sensors, with superior field detection sensitivity compared to traditional magnetoresistive (MR) sensors, do not rely on thin film deposition or micro/nanofabrication facilities and do not require a magnetic shielding room, low temperatures, or regular maintenance like SQUID, potentially revolutionizing cardiac health monitoring.